SERUM AND CEREBROSPINAL FLUID ALPHAFETOPROTEIN LEVELS IN NEWBORNS

Discarded samples of serum and cerebrospinal fluid from newborn infants suspected to have sepsis will be analysed to establish normal values for cerebraspinal fluid alphafeto-protein (AFP) levels in these sick infants and to establish any correlation between serum and cerebrospinal fluid AFP levels.